Signaling pathways in tumoricidal macrophages in pancreatic cancer

Project Summary
Macrophages are active phagocytes and play important roles in engulfment of pathogens, clearance of dead
cells and immune complexes, and tissue repair, as well as clearance of live cells including aged red blood cells
and neutrophils. Most of the known pro-phagocytic interactions rely on plasma membrane lipid changes in target
cells as they start to become apoptotic; how neoplastic or damaged cells are distinguished from healthy cells is
not fully understood. We discovered that mouse and human macrophages treated with cIAP1/2 antagonism and
the cytokine lymphotoxin (LTα1β2) or IFNγ become strongly phagocytic and can engulf live tumor cells. This live
cell phagocytosis occurs in the absence of antibodies and is independent of CD47 and calreticulin, demonstrating
that unidentified pro-phagocytic pathways must exist. Moreover, chemogenomic screening of deubiquitinase
inhibitors identified a chemical series that also induces live cell phagocytosis, indicating the robustness of this
macrophage cell state. Our long-term goal is to identify the receptor-ligand interactions governing live cell
phagocytosis. Our central hypothesis is that pro-phagocytic receptors on macrophages are dynamically
regulated by the ubiquitin/proteasome system and recognize constitutively expressed ligands on malignant or
damaged target cells. In Aim 1, we will define the role of deubiquitinases in regulation of macrophage surface
receptors governing recognition and phagocytosis of live cells. We identified the ubiquitin-editing enzyme
TNFAIP3 as a promising regulator of phagocytosis. We will validate the role of TNFAIP3 in induction of
phagocidal macrophages and identify the downstream signaling and surface proteins on macrophages regulated
by TNFAIP3 that mediate recognition and/or phagocytosis of live cancer cells. Unbiased proteomics analysis of
phagocidal macrophages induced by deubiquitinase inhibitors revealed the upregulation of fatty acid
desaturases, which we will study in aim 1.3. In Aim 2, we will determine the extent to which live cell phagocytosis
by macrophages is a means of tumor destruction in vivo. Here we will develop fluorescence-based reporter
constructs that can be inserted into any cancer model to distinguish between tumor cells that died and were
taken up by efferocytosis versus true phagocytosis of live cells in vivo. Using this novel PhagoGLO in vivo
reporter system, we will be able to quantify the ratio of live cell versus dead cell phagocytosis in vivo, both in
terms of endogenous anti-tumor immunity and in the context of macrophage-targeted therapies or innate immune
agonists. We will also test candidate genes from Aim 1 to determine their impact on live cell phagocytosis in
vivo. Collectively this proposal will define novel regulators of live cell phagocytosis and expand our ability to
therapeutically impinge or enhance macrophage phagocytic activity, as well as generate a technologically
innovative in vivo platform for studying macrophage phagocytosis in tumors that will both meet the needs of this
current project and launch my successful independent career studying macrophage cell biology in the context of
cancer therapies.

Public health relevance
Project Narrative This proposal focuses on reprogramming macrophages which are abundantly present in the tumor environment to phagocytose and destroy live tumor cells. Our studies will provide a mechanistic understanding of live cell phagocytosis and generate a technologically innovative in vivo platform for studying macrophage phagocytosis in tumors, thus paving the ways for new druggable targets for recalcitrant tumors.